Neural Mechanisms of Fatigue in Post-Acute Sequela of SARS-CoV-2

PROJECT SUMMARY
Coronavirus disease 2019 (COVID-19) is caused by severe acute respiratory syndrome coronavirus 2 (SARS-
CoV-2) and has led to a global pandemic, infecting more than 760 million people worldwide. Although
COVID-19 was initially described as a respiratory disease, there is growing evidence that SARS-CoV-2
impacts the nervous system and causes impairments that may last long after the acute phase of the disease.
This spectrum of persistent symptoms is called Post-Acute Sequelae of SARS-CoV-2 Infection (PASC) or Long
COVID. Physical fatigue is one of the most common symptoms associated with PASC, yet there is a limited
understanding of its behavioral and neural mechanisms. Neuroinflammation is thought to be a primary
contributor to feelings of fatigue in many neurological disorders, including PASC, and brain blood-brain barrier
(BBB) injury is a hallmark of neuroinflammation. Despite the potential links between PASC, BBB dysfunction,
and fatigue, their relationship has yet to be studied. To this end, we will use a combination of experiments in
human participants, computational modeling of behavior, and neuroimaging. The central hypothesis of this
proposal is that individuals with PASC will have increased BBB permeability from COVID infection, which
disrupts neural processing of effort, resulting in increased feelings of physical fatigue. Aim 1 will determine the
relationship between BBB permeability and neural and behavioral representations of effort assessment in
individuals with PASC suffering from fatigue. We will collect measures of BBB permeability in PASC patients,
have them make assessments of effort, and scan their brains with fMRI while they make these judgments. This
data will allow us to study how disruptions in effort assessment are related to COVID-19-induced changes in
BBB permeability, and their influence on the neural representations of effort. In Aim 2, we will investigate how
BBB permeability influences individuals with PASC's immediate response to bouts of fatiguing exertion and the
underlying neural processes. We will have individuals perform bouts of fatiguing exertion and simultaneously
scan their brains with fMRI. This data will allow us to study how individuals with PASC's feelings of fatigue (and
associated neural activity) evolve, and how COVID-induced increases in BBB permeability mediate these
changes. In Aim 3 we will evaluate how BBB permeability changes through the time course of PASC and how
these changes are related to behavioral and neural representations of fatigue. Over the course of a year, we
will collect measures of BBB permeability in individuals with PASC and have them assess their levels of effort
exertion and perform effort-based decision-making tasks while scanned with fMRI. In sum, our proposed
studies will provide an understanding of the neurobiological mechanisms of fatigue in PASC. This knowledge
will eventually provide candidate mechanisms to target with pharmacological intervention and inform
rehabilitative care for those individuals suffering from symptoms of fatigue in PASC.

Public health relevance
PROJECT NARRATIVE This proposal aims to understand the neurobiological mechanisms of fatigue in individuals with Post-Acute Sequelae of SARS-CoV-2 Infection (PASC). This knowledge will eventually provide candidate mechanisms to target with pharmacological intervention and inform rehabilitative care for those individuals suffering from symptoms of fatigue in PASC.